Delayed wound healing in diabetic corneal epithelia: reduction in protein response after injury and uncoordinated cell-cell communication

Non-healing corneal injuries affect up to 70% of patients with type 2 diabetes, representing a significant cause
of vision loss in this population. Although there are treatments available to improve the symptoms of poorly-
healing corneal wounds, the only permanent solution is a corneal transplant, a procedure not readily available
worldwide. By examining changes in various proteins involved in the wound healing response at the cellular
level, I hope to understand why the corneas of diabetic patients fail to heal effectively. When an otherwise
healthy cornea is injured, cells next to the wound experience a number of changes necessary for coordinated
migration and wound closure. One change involves the activation of the purinergic receptor, P2X7, found on
the cell surface. When active, P2X7 generates a specific pattern of calcium signaling events that travel from
cell to cell through activation of the ion channel Pannexin-1. These propagated signaling events represent cell-
cell communication, and ultimately lead to re-arrangement of cytoskeletal proteins and coordinated wound
closure. Our previous studies have identified aberrant localization and activation of P2X7 in pre-type 2 diabetic
models. We have preliminary evidence that the signaling profile of wounded diabetic cells lacks the
characteristic P2X7 signaling response. This was confirmed using specific agonists to P2X7, and observing a
greatly diminished response in diabetic cells. The goal of this proposal is to uncover how the cell-cell
communication events in the P2X7 signaling cascade are regulated, how this regulation is thrown off in
diabetic systems, and how this change in regulation affects actin bundling and ultimately cell motility. My
preliminary data has identified a set of cells that we speculate are controllers or leader cells, as they initiate
communication events in neighboring cells, and propagated signaling events are greatly reduced in their
absence. Aim 1 will use a machine learning approach to investigate the presence of these leader cells in both
diabetic cell culture and corneal models. Aim 1 will also address the role of Pannexin-1 in the generation of a
unique leader cell signaling profile. Furthermore, the downstream impact of P2X7/Pannexin-1 signaling will be
assessed by using 3D electron microscopy to study actin arrangement in wounded diabetic and control
corneas. In Aim 2, the localization of P2X7 and Pannexin-1 protein and mRNA within the cells of corneal
samples will be examined. This will yield data regarding both general trends in expression between diabetic
and control groups, and differences in expression within a single sample that may explain the functional
difference between leader cells and the rest of the epithelial sheet. In addition, Aim 2 will address whether the
co-localization of P2X7 and Pannexin-1 proteins (before and after a wound) is necessary for wound repair.
Together these Aims will produce significant advances in our understanding of the regulation of the
P2X7/Pannexin-1 signaling cascade, alterations at the mRNA, protein, and functional level of this cascade in
diabetes, and downstream effects of these aberrations on the actin cytoskeleton.

Public health relevance
Injury to the cornea can be painful and compromise vision, especially in people with diabetes. For a cornea to heal cells need to talk to one another using signals from proteins that act like sensors, a process that does not work well in diabetic corneas. The goal of this proposal is to look at the interactions between two important sensing proteins to see why cells have a hard time talking to each other in diabetes.